Administrative Supplement: Enhance the Utility of Data Available through the Childhood Cancer Data Initiative (CCDI) Ecosystem

PROJECT SUMMARY/ABSTRACT
The National Cancer Institute (NCI) Childhood Cancer Data Initiative (CCDI) is building an ecosystem to gather
data and learn from all patients with childhood cancer. An important component of this is increasing the
availability of longitudinal clinical data that can be integrated with other crucial data submitted to the CCDI. The
current standard practice for acquiring these types of data is manual abstraction by a clinical research
coordinator, which is time consuming and subject to human error. Electronic health records (EHRs) have the
potential to expand the amount of data flowing into the CCDI ecosystem. However, they also present several
challenges due to lack of structure and standardization. This objective of this study is to combine two
previously developed approaches to obtaining data in order to provision clean, clinically-relevant data to the
CCDI. The first package, ExtractEHR, extracts data from the EHR, and utilizes a series of post-processing
coding to transform the raw EHR data into clinically relevant, human understandable data about the childhood
cancer experience. The second approach uses Fast Healthcare Interoperability Resources (FHIR)-based
methods to provide a technical framework for more scalable workflows and interchange of clinical data.
This study aims to combine ExtractEHR with the FHIR framework development to enable the expansion of
clinical data available to CCDI. The proposal will determine scalable ways for ongoing contributions by
achieving the following two specific aims. The first aims is to extract and process EHR data to provide clinical
context regarding treatment and outcomes for patients with molecular data in the CCDI ecosystem. To achieve
this goal, ExtractEHR will be extract data on patients previously consented to Children’s Brain Tumor Network
(CBTN) protocols at two large children’s hospitals, the Children’s Hospital of Philadelphia (CHOP) and
Children’s Healthcare of Atlanta (CHOA). Extracted data will be processed to provide clinically-relevant
treatment and outcomes data that will be transferred to the CCDI. This will demonstrate the feasibility and
operability of a seamless workflow by delivering a set of EHR data to CCDI to facilitate collaboration and
discussion with CCDI teams on which aspects of the workflow or data to optimize and/or expand on. The
second aim is to develop a FHIR-based version of ExtractEHR and determine its scalability and success in
interacting with the post-processing workflow needed to obtain clinically meaningful data. Efforts will be made
to export ExtractEHR functionality into a FHIR framework at CHOP and to test this process at CHOA.
This study will create pipelines that provide granular data from cleaned and processed EHR data that offers
clinical context for patients included in the CCDI and will determine if FHIR-based approaches can be used as
a scalable method for using ExtractEHR to ascertain data to be included in the CCDI ecosystem.

Public health relevance
PROJECT NARRATIVE Electronic health record data are recorded as part of routine clinical care but have the potential to be used more broadly for research and surveillance. The goal of this proposal is to develop workflows to extract and process electronic health record data to provide treatment and outcome clinical data from real-world patients that will expand the Childhood Cancer Data Initiative ecosystem. This data can be used to better characterize the experience of patients undergoing treatment for childhood cancer.